APOL1 as a model to quantify and identify environmental modifiers of genetic associations in diverse populations

PROJECT SUMMARY
Complex human traits and outcomes have substantial genetic and environmental contributions that, when
identified, lead to a better understanding of underlying biological process and are potential targets of prevention,
intervention, and treatment strategies. Advances in genotyping and sequencing technologies over the last 20
years has enabled a golden age of genomic discovery, resulting in the identification of thousands of genome-
wide genotype-phenotype associations. Comparatively, the identification of modifiers of these genetic
associations has been slow. And most interrogations of modifiers of genetic associations have been limited to
select non-genetic variables such as sex and age or exposures such as smoking. Relatively few have explored
the impact of social determinants of health despite their independent associations with health disparities.
Regardless of the modifier under study, their identification requires large, well-phenotyped and diverse cohorts
with exposure and genome-wide data available for powerful statistical analysis. Compounding the challenge is
defining the phenotype or outcome of interest generalizable to populations but still useful in specific clinic
settings.
The relatively recent availability of UK Biobank and All of Us, among other diverse datasets linked to phenotypes,
exposures, and genome-wide data, makes the earnest search for environmental modifiers of genetic
associations possible. Here we propose to use APOL1 as a model and possible framework for the methodical
search for environmental “second hits” that distinguish truly at-risk participants and eventually patients from
others. APOL1, associated strongly with negative kidney outcomes that disproportionately affect African
Americans, is an ideal model given that its renal risk variants are 1) common among African-descent and
admixed groups and 2) found exclusively on African-specific haplotypes. We aim to access NEPTUNE, UK
Biobank, and All of Us to quantify the evidence that APOL1 genetic risk for rare (focal segmental
glomerulosclerosis or FSGS) and common negative kidney outcomes (albuminuria, kidney-disease related
eGFR, and composite chronic kidney disease) is modified using observed heterogeneity in its effect sizes across
populations (African Americans, British Blacks, and Hispanics). We further aim to interrogate potential modifying
effects of heavy metal exposure, a quantitative marker association with social determinant of health. The Specific
Aims proposed here, when accomplished, will provide additional data toward at-risk profiles for APOL1 renal risk
variant carriers useful for clinical risk prediction models as well as targets for prevention efforts and/or
development of novel therapeutics. The accomplished Aims will also provide a framework for the systematic
interrogation of “second hits” relevant for human outcomes with known genetic associations.

Public health relevance
PROJECT NARRATIVE Complex human diseases have both environmental and genetic contributors. While many independent genetic associations have been identified, missing is our understanding of how environmental exposures modify these associations. We propose here to use APOL1-mediated kidney disease as a model and eventual framework to identify these “second hits” that distinguish true at-risk patients from APOL1 renal risk variant carriers.